Biochemical and Chemical Training for Cancer Research

Project Abstract
This renewal application seeks support for the training of predoctoral students and postdoctoral
fellows in biochemical, chemical, biological and structural approaches for cancer research. The
training program integrates contemporary cancer biology (e.g., oncogenes and tumor
suppressors, signal transduction, oncogenic transcription factors, DNA modifications, cell cycle
control, genomic surveillance) with the allied fields of chemical biology, chemical-genetics, and
structural biology. Over the past 35 years, this Training Program has an outstanding training
record and seeks to continue this multidisciplinary training program that is composed of 29
preceptors from nine academic departments and programs representing the Vanderbilt University
School of Medicine, School of Engineering, the College of Arts and Sciences and the Vanderbilt
University Medical Center. The training program is conducted within a vibrant academic
environment and is supported by close interactions with the Vanderbilt-Ingram NCI-designated
Comprehensive Cancer Center, the Vanderbilt Institute of Chemical Biology, and the Vanderbilt
Center for Structural Biology, all of which offer resources for trainees and preceptors. In addition
to departmental and preceptor-specific laboratory instruction, each trainee receives cancer-
related training in the form of three courses focused on cancer biology and experimental cancer
research. An Interdisciplinary Graduate Program (IGP), the Chemical and Physical Biology
Program (CPB), and an independent graduate program in Chemistry all academically support
predoctoral trainees. This renewal applications continues several recent enhancements to our
training program including a Precision Cancer Medicine course that provides an immersive clinical
experience. In the COVID era, we have also lauched 15 bioinformics micro-training courses for
large datasets. We have an active mentoring program that includes former student trainees,
postdoctoral mentors, and faculty mentors, which ensures the continued development of
academic skills for cancer research and career development. Significant institutional investment
in training programs, core facilities, state-of-the-art laboratories and equipment that provide
technology resources applicable to cancer biology and molecular structures also enhance trainee
development. The institution has also made additional investiments to provide an inclusing
training environment that his free of any form of harassment or discrimination while emphasizing
rigor, reproducibility and transparency. This integrated training in biochemistry, chemistry,
structural biology, and cancer biology is critical to the molecular understanding of cancer and the
development of new approaches to molecularly targeted therapeutics.

Public health relevance
Project Narrative This renewal application seeks support for the training of predoctoral students and postdoctoral fellows in biochemical, chemical, chemical-genetic, biological and structural approaches for cancer research. Integrated training in biochemistry, chemistry, structural biology, and cancer biology is critical to the molecular understanding of cancer and the development of new approaches to molecularly targeted therapeutics.